Frustration effects on drug taking

ABSTRACT
Although not pleasant, frustration is an important state, as it acts as a check on aberrant motivation. Conditions
of high motivation (e.g. substance use disorders [SUDs]) can arise when frustration fails to decrease
motivation (i.e. inelasticity of demand). We have developed a way of measuring frustration-related behavior
during operant responding in rats by looking at barpress durations. Having satisfied 9 fundamental criteria for
determining barpress durations as a measure of frustration-related behavior, the current project will determine
fundamental neurobiological aspects of frustration as it relates to decreased motivation for drug. We
hypothesize that individual differences in motivation are determined in part by frustration, with frustration
having distinct early life environmental determinants and specific neurocircuitry converging on motivation
pathways. We contend that frustration is distinguishable from drug motivation and plays an important role in
attenuating motivation for drug. Many suffering from SUDs are insensitive to frustration, meaning that
frustrating conditions do not decrease motivation appropriately. This project will utilize two well-characterized
rat behavioral tests for drug motivation, namely behavioral economic assessment of demand elasticity and
progressive ratio determination of drug value. The project will address key aspects of 1) early-life factors
conferring individual differences in frustration behavior as determinants of susceptibility and resilience to drug
motivation, 2) the role of key frustration-related neurocircuitry projecting to the shell of the nucleus accumbens
(shNAc), and 3) effects on shNAc medium spiny neuron output on frustration and motivation behavior. Thus,
Aim 1 of this project will investigate the development of individual differences in frustration-related behavior
subsequent to adolescent exposure to risk/resilience factors such as chronic unpredictable mild stress and
environmental enrichment/isolation, each known to affect motivation for drug. The question is whether the
already known effects on motivation are mediated through frustration. Additionally, chronic frustration during
adolescence will assess whether this manipulation inoculates against, or predisposes to, later sensitivity to
frustration as it affects drug motivation. Aim 2 will utilize a combinatorial chemogenetic approach for
manipulating four specific pathways for frustration and/or motivation to discern the circuitry integration of
frustration with motivation to affect behavior. Aim 3 will assess effects of frustration on shNAc output neurons
and the effects of shNAc output on motivation for drug. To be clear, the proposed therapeutic strategy is not
high frustration itself, but rather normalizing the ability for frustration to check drug motivation. Understanding
the neurobiology of frustration-attenuated motivation is the first major step in developing this novel approach.

Public health relevance
PROJECT NARRATIVE For many with substance use disorder, motivation for drug is not appropriately blunted by frustration, meaning that recoupling frustration with decreased motivation is a novel therapeutic strategy. We have developed a method of quantifying frustration-related behavior in rats during operant responding which now allows us to study frustration effects on motivation in real time. This project will determine adolescent factors contributing to individual differences in frustration behavior and identify how frustration-related neurocircuitry couples to decreased cocaine motivation.